Chemical tools to investigate chain-flipping in quorum signal synthases

Abstract
Gram-negative bacteria use acyl-homoserine lactone mediated quorum sensing to regulate key physiological
activities that includes virulence, biofilm formation and toxin production. AHL synthases make AHL
autoinducer signals by enzymatically coupling acyl-ACP and S-adenosyl-L-methionine metabolites to
facilitate quorum sensing for the bacterium. Therefore, AHL synthase inhibitors hold significant promise as
antimicrobials in treating multidrug resistant bacterial infections. Designing AHL synthase specific inhibitors,
however, does remain a significant challenge. To develop QS selective inhibitors, we investigate unique
functional aspects of AHL synthases that distinguish them from other enzymes utilizing either acyl-ACP or
SAM substrates. One such unique aspect of the synthase is it’s ability to selectively bind and react with a
specific acyl-ACP substrate thereby enforcing fidelity in AHL signal synthesis. In general, acyl-ACP binding
to a partner enzyme is a minimal two-step process involving an initial electrostatic docking of ACP acidic
residues on to a basic patch in the synthase (protein-protein binding) followed by the translocation of the acyl-
chain cargo from the ACP to the enzyme’s active site pocket through a process referred to as “chain-flipping”.
Decoupling the binding from the chain-flipping step was not possible until now due to lack of methods that
could independently report on the chain flipping step in ACP utilizing enzyme reactions. To address this
limitation, we placed a site-specific fluorescent label on the EsaI AHL synthase, conducted enzyme-ACP
titrations in the pre-steady state kinetics regime using a stopped flow fluorometer and determined kon and koff
for both fluorescent and non-fluorescent cargo chain flipping from ACP to the EsaI synthase. Building upon
our preliminary data, we propose two aims in this application to validate a fluorescence based method for
determining chain-flipping rate constants in AHL synthase enzymes. Successful completion of the proposed
studies should a) enhance our understanding on the mechanistic basis of substrate recognition in AHL
synthases b) aid in development of a fluorescence-based HTS assay for screening AHL synthase inhibitors
and c) open doors for single molecule enzymological investigations on chain-flipping step in AHL synthesis
and d) facilitate deployment of this tool to investigate chain-flipping kinetics over a broader range of
medicinally important, carrier protein dependent enzymes.

Public health relevance
PROJECT NARRATIVE STATEMENT Research described in this application will validate tools for determining chain flipping rate constants in AHL quorum signal synthase enzymes. This information is critical to achieve selectivity in quorum sensing inhibition. Small molecules that selectively modulate quorum sensing will provide valuable leads for developing novel antivirulent compounds in antibacterial therapy.